A novel mechanism regulating genome-wide mRNA expression in hypoxic lung disease

Project Summary/Abstract
Hypoxia, a key contributor to multiple lung diseases, evokes functional and structural responses in target cells
by modulating expression of many hundreds of genes. Much is known about regulation of the hypoxic
transcriptional response at the single gene level. Induction begins with the reactive oxygen species (ROS)-
mediated accumulation hypoxia-inducible transcription factors (Hifs) which, along with coactivators, assemble
into multiprotein complexes on hypoxia response elements (HREs) located in gene promoters, enhancers, and
perhaps intergenic regions to activate transcription. Far less is known, however, about orchestration of the
transcriptional response to hypoxia on a genomic level, with many incongruities between hypoxic exposure, Hif-
HRE interactions, and local chromatin restructuring highlighting unresolved complexities of the regulatory
apparatus. This proposal addresses the prospect that hypoxia activates a pathway operating in concert with the
Hifs to govern the hypoxic transcriptome. Our foundational discoveries along with rapidly accumulating evidence
from other fields converge on the concept that ROS generated in hypoxia to initiate Hif accumulation also cause
widespread oxidation of guanine to 8-oxoganine (8-oxoG) in distinct motifs nested within DNA regulatory
sequences. Oxidized guanines then serve as a novel epigenetic mark by recruiting bifunctional enzymes
comprising the DNA Base oxidation and repair pathway (BER). Along with repairing oxidized bases, two of these
BER components, specifically OGG1 and Ref-1APE1, direct deployment of canonical enzymes modifying
histone acetylation and methylation, thereby governing chromatin accessibility. We call this pathway “BRACR”
for Base oxidation and Repair Activated Chromatin Restructuring, and here we propose to explore the novel
concept that BRACR is a fundamental component of the gene regulatory apparatus in hypoxia, acting to
license HREs and other response elements for transcription factor occupancy by modulating chromatin
accessibility. Using cultured human pulmonary arterial cells and intact mice, we will test the hypotheses that:
(1) the genome-wide deployment of BRACR in hypoxia requires 8-oxoG formation but not Hifs; (2) BRACR
licenses genes for hypoxic regulation through 8-oxoG-mediated engagement of the BER enzymes Ogg1 and
Ref-1/APE 1; and, (3) BRACR activation in lung vascular cells drives hypoxic pulmonary hypertension in intact
mice. These studies will be transformative. They will define a novel mechanism regulating the hypoxic
transcriptome on a genome-wide level, identify new pharmacologic targets to treat hypoxic lung diseases, and
because 8-oxoG is mutagenic, may point to a link between transcriptional signaling and somatic mutations that
drive malignant and non-malignant pulmonary disorders.

Public health relevance
Project Narrative Adaptation to hypoxia by lung cells, an important pathogenic factor in respiratory medicine, involves expression of hundreds of genes. Our discoveries add a new dimension to signaling in this setting by showing that hypoxia harnesses a pathway involving controlled DNA oxidation and repair to modulate the macrostructure (chromatin) of DNA thereby orchestrating expression of hypoxia responsive genes. This research will delve into the mechanism of the DNA structural modulation by base oxidation and repair and define its utility as a drug target in hypoxic lug disease.